Examining the Role of CVB in the Generation of Beta Cell Neoantigens and Targeted Approaches at Therapeutic Intervention

Type 1 diabetes (T1D) is an autoimmune disease that results from the targeting and destruction of
pancreatic islet β cells by autoreactive immune cells, including CD4+ T cells. The cellular processes that
break immune tolerance in individuals genetically predisposed to autoimmunity are poorly understood. In
particular, very little is known about the events that occur at the islet-immune interface that cause auto-
immune targeting of β cells. While identifying β cell autoantigens is of great importance, elucidating how β
cell proteins become immunogenic is crucial. Many environmental and physiologic factors associated with
T1D, including Coxsackie virus B (CVB) infection, can induce endoplasmic reticulum (ER) stress/dysfunction
increasing ER dysfunction and the potential for abnormal handling and post-translational modification (PTM)
of proteins. The subsequent presentation of these abnormally modified proteins (neo-antigens), by antigen
presenting cells (APC) to T cells breaks immune tolerance and exacerbates pathology in many diseases,
including T1D. In the context of genetic susceptibility to autoimmunity and failure of peripheral tolerance,
the presentation of abnormally modified proteins by antigen presenting cells (APC) to T cells initiates
pathology in a number of diseases. Therefore, ER stress induced for example, by CVB infection, within β
cells may generate abnormally modified proteins that act as neo-antigens for the autoimmune response in
T1D. Indeed, our work demonstrates that endoplasmic reticulum (ER) stress in b cells increases cytosolic
calcium Ca2+ and the activity of tissue transglutaminase 2 (tTG2), leading to PTM generation by deamidation
forming neo-epitopes and increasing T cell recognition. Furthermore, we have shown that subjects with T1D
have elevated frequencies of T cells that recognize deamidated neo-epitopes and that T cells with these
specificities can be found in the pancreatic lymph nodes of organ donors with T1D. Hence, it is plausible
that T cells that recognize deamidated epitopes, resulting from CVB triggered ER stress induced Ca2+ flux
and activation of tTG2 enzymes become activated and expanded in subjects who progress to develop type
1 diabetes. Furthermore, recent work demonstrates that enterovirus family members show a strong
association with islet autoimmunity in human T1D patients and a sizeable percentage of type 1 diabetic
patients have prolonged/persistent enterovirus infection associated with gut mucosa inflammation. To
assess the role of CVB infection in T1D progression we will define the mechanisms by which CVB infection
affects ER stress-mediated PTM of β cell proteins, contributing to β cell immunogenicity in human islets in
vitro, and further determine the mechanism by which CVB infection causes a break in tolerance and
accelerated disease in vivo. We will also assess therapeutic strategies that impede these enzymatic
mechanisms to affect T1D progression.

Public health relevance
The proposal aims to study a non-canonical role in the viral etiology of T1D, specifically the mechanisms associated with viral entry, Ca2+-flux, induction of ER stress and how they contribute to the generation of neoantigens, that can further accelerate the loss of tolerance to b cells. These studies are of great importance and relevance to T1D as they will further define the mechanisms responsible for progression of T1D in individuals genetically predisposed to autoimmunity. Such mechanistic studies are necessary to understand how a known environmental trigger can contribute to the biological processes leading to the generation of autoantigens and better educate us in the design of therapeutic strategies to prevent these processes.